Regulation of bone marrow homing by hematopoietic stem cell vesicles

PROJECT SUMMARY/ABSTRACT
The goal of the proposed five-year training plan is the development of my independent research career as an
academic hematopathology physician-scientist studying hematopoietic stem and progenitor cell (HSPC)
crosstalk and transplantation. I am currently a research fellow at the Children’s Hospital of Philadelphia (CHOP)
and attending physician in the Division of Hematopathology at the University of Pennsylvania (UPenn). I am
specifically seeking to develop and refine skills required for my successful career as an independent investigator,
including expertise in HSPC transplantation and microscopy, miRNA mimic and inhibitor screening, lipid
nanoparticle delivery, and bioinformatics. My overarching goal is to improve HSPC transplantation outcomes
through study of key mechanisms of HSPC-niche cell crosstalk. My mentor for this award is Dr. Peter Kurre, a
recognized leader in hematopoietic stem cell biology and bone marrow (BM) failure syndromes. To further add
to my scientific and career guidance, I have assembled a mentoring committee composed of scientists and
physician-scientists from complementary research fields. I will have the full resources and support of UPenn and
CHOP available for the completion of my research and career development goals.
This proposal outlines experimental plans to define mechanisms of cellular crosstalk between HSPCs and BM
ECs that will inform potential strategies for improving HSPC transplantation. Graft success after transplantation
requires initial homing of donor HSPCs to the bone marrow niche, a specialized vascular microenvironment that
supports long-term blood cell and immune system reconstitution. BM migration is a dynamic process involving
various adhesion and signaling molecules that are not completely defined. My preliminary data have elucidated
a novel mechanism of crosstalk between HSPCs and ECs that initiates from cargo trafficked by secreted
extracellular vesicles (EVs). Specifically, HSPC EVs promote remodeling of ECs and lead to reciprocal CCR2
receptor-ligand interactions that likely interact with CXCR4 to drive HSPC migration. This proposal will define
the molecular mechanisms underlying EC remodeling and HSPC migration, and investigate innovative pre-
conditioning strategies to recapitulate and exploit physiologic mechanisms with the goal of improving HSPC
transplantation outcomes. These objectives will be achieved via three specific aims: to elucidate key signaling
pathways driving EC remodeling, to define CCR2 cooperativity in BM homing, and to test pre-conditioning
strategies to induce EC CCR2 ligand upregulation and enhance HSPC engraftment. The outcome of these
studies will deepen our understanding of HSPC-niche crosstalk and unveil new therapeutic strategies to optimize
HSPC transplantation. Completion of these aims will consolidate my experience in models of murine HSPC
transplantation and EV-mediated signal transduction, further my training in nanoparticle-based in vivo delivery,
and provide the basis for a future R01 funding proposal, leaving me uniquely prepared for an independent career
as a physician-scientist with a focus on HSPC transplantation.

Public health relevance
PROJECT NARRATIVE While hematopoietic stem and progenitor cell (HSPC) transplantation is a curative therapy for many malignant and monogenic pathologies, graft failure remains a serious cause of patient morbidity and mortality. I have recently identified a novel mechanism of reciprocal HSPC-endothelial cell crosstalk via secreted vesicles that ultimately drives enhanced HSPC bone marrow (BM) migration; this project proposes to further investigate and recapitulate the signaling pathways guiding initial HSPC BM homing and engraftment. Results from this study will inform new preconditioning strategies to improve HSPC transplantation.